DEVELOPMENT OF INHIBITORY FUNCTION IN THE CORTEX

This series of experiments is designed to study in detail the maturation of inhibitory function associated with synaptogenesis during early development. The unique features of the cortex of the turtle Pseudemys scripta, will be exploited in these experiments. The turtle cortex contains primarily pyramidal cells and GABAergic inter-neurons distributed in three distinct laminae. Initial studies have demonstrated that corticogenesis and synapse formation proceed through stages. The GABAergic machinery localized in interneurons, and the GABA receptors located on pyramidal cell membranes develop very early in corticogenesis, well in advance of cortical plate formation and the development of synapses. The proposed studies now seek to explore the stages of functional synaptogenesis in greater detail. Single neurons dissociated from embryonic cortex will be used in patch clamp studies to examine the development of postsynaptic receptors for the inhibitory amino acid GABA and the excitatory amino acid glutamate. In particular, development of GABA and NMDA receptors will be characterized both physiologically and topographically. Vibratomed embryonic cortical slices will be used to obtain whole cell recordings and to study the physiology of early appearing inhibitory and excitatory postsynaptic potentials. Morphologic studies using immunohistochemically stained tissue and electronmicroscopy will help to correlate ultrastructural features of early-appearing synapses with the physiological data. The timetable for development of epileptogenesis will also be studied utilizing pharmacological approaches to alter the effectiveness of excitatory and inhibitory synapses at early stages of development. The proposed studies will provide a high resolution timetable for the development of physiologically active inhibitory and excitatory synapses in cortex. Since the balance between inhibitory and excitatory function is crucial for regulating cortical excitability, these experiments will provide information that may help explain the unique susceptibility of developing cortex to epilepsy.